Quantitative Cu-Homeostasis in Live Mammalian Cells at the Single-Molecule Level

PROJECT SUMMARY/ABSTRACT
Understanding responsive mechanisms of metalloproteins is key to elucidate biological functions of copper (Cu)
and to identify the causes of diseases resulting from abnormal metal homeostasis. The cellular Cu uptake and
secretion require relevant metalloproteins to adjust in a spatiotemporally coordinated manner to assure proper
cellular Cu level. However, in the Cu field, little is known about how metalloproteins are individually regulated
nor systematically cooperate with each other in their native environment, i.e., in cells. Our research goal is to
understand the responsive mechanisms of Cu-uptake and secretory metalloproteins in live mammalian cells,
with specific focuses on how metalloproteins adjust their behaviors such as spatial distributions, oligomeric states,
inter-protein and inter-domain interactions for proper Cu balance in a spatiotemporally defined manner. Previous
achievements of the PI include discoveries of novel mechanisms of MerR-family metalloregulators in regulating
transcription and Cu-responsive dynamic assembly of efflux pumps by examining the protein-DNA interaction
and protein diffusive behaviors in live bacteria using single-molecule super-resolution microscopy. Leveraging
the power of these technologies, in combined with the recently developed live-cell single-molecule fluorescence-
resonance-energy-transfer assay, we will elucidate the responsive mechanisms of metalloproteins in the uptake
and secretory pathways in live mammalian cells. Using CTR1 and ATOX1-ATP7A/B as the initial examples of
uptake and secretory metalloproteins, the proposed experiments will (1) quantify Cu-dependent oligomeric state
distribution and identify the Cu-responsive moiety of CTR1; (2) define the preferential interaction of ATOX1 to
ATP7A and ATP7B and how mutations in ATP7B affect Cu homeostasis in cellular Cu defending using induced
pluripotent stem cells derived hepatocytes. In addition to primary approaches of single-molecule super-resolution
fluorescence imaging techniques, complementary bulk spectroscopic and biochemical measurements will be
compared. The research program is further enhanced by collaborations with the experts in Cu homeostasis and
stem cell fields. The research is significant because it will provide mechanistic insights into metalloprotein-
mediated Cu-uptake and secretion processes as well as complementary information for synchrotron X-ray
fluorescence studies on intracellular Cu-redistribution. The comparison between human induced pluripotent stem
cell (hiPSC)-derived healthy and diseased hepatocytes will inform how disease mutations disrupt cellular Cu
balance, providing the knowledge base to devise therapeutic strategies for Wilson's diseases. The research is
innovative because it represents a substantive departure from the status quo by shifting focus to define response
mechanisms of metalloproteins using advanced approaches including single-molecule super-resolution
microscopy and hiPSC-derived hepatocytes. The live-cell imaging approach also circumvents the general
challenge in studying membrane complexes, whose in vitro reconstitution is technically demanding. The hiPSC-
derived diseased hepatocytes provide an ideal platform to study the pathogenesis of Wilson's disease.

Public health relevance
PROJECT NARRATIVE The proposed research is relevant to public health because the mechanisms identified will increase the understanding of the role of metalloproteins in and the effect of Wilson disease mutations on Cu homeostasis in live mammalian cells, providing the knowledge base to devise therapeutic strategies to these diseases. Thus, the proposed research is relevant to the part of NIGMS's mission that pertains to developing fundamental knowledge that will lay the foundation for disease treatment and prevention.